Multiplexed CRISPRa/i in primary immune cells to elucidate gene regulatory networks underpinning T cell development

PROJECT SUMMARY
Immune cells adopt distinct cell type identities and functional states to enable robust defense against diverse
challenges. These distinct cell types and states are established by networks of interacting transcription factors,
chromatin regulators and cis-regulatory elements. Many key molecular components of these gene regulatory
networks are now identified; however, it remains unclear how they work together to orchestrate immune cell
state transitions. This gap is in part due to the lack of strategies to concurrently turn on or off multiple components,
and thereby probe their identities and modes of interaction. CRISPR/Cas9 technologies can facilitate recruitment
of distinct transcription effectors to different loci, thus potentially enabling concurrent activation and repression
of different genes in the same cell. However, current CRISPR activation (CRISPRa) or interference (CRISPRi)
systems are challenging to implement in primary immune cells. Furthermore, current systems often still show
weak and variable effects at target loci, precluding their systematic deployment in diverse immune contexts.
These challenges will be overcome by developing a compact viral system for robust, concurrent CRISPR
activation and interference (CRISPRa/i) in primary murine immune cells (Aim 1). This system will have the
following innovations: (1) CRISPR RNA-scaffolds to recruit distinct transcriptional effectors to different loci in the
same cell using a single Cas9 protein; (2) next-generation hypercompact effectors with high transcriptional
efficacy; and (3) use of truncated (14-15 nt) scaffold RNAs that will render this system compatible with the widely-
used Cas9 knock-in mouse strains. The system will be developed in primary mouse progenitors and optimized
for system designs that show both high efficacy and reliability in the targeting of multiple genes. Next, this
compact CRISPRa/i system will be used to map the landscape of interactions in the gene regulatory
network controlling Bcl11b activation and T cell lineage commitment (Aim 2). The transcription factor
Bcl11b is essential for T cell lineage identity; its irreversible all-or-none activation shuts down alternate fate
options and commits progenitors to the T cell lineage. Here, a series of single and pairwise CRISPR activation
and interference screens in multipotent progenitors will identify transcription factors, chromatin regulators and
cis-regulatory elements controlling Bcl11b activation. These studies will identify the gene regulatory network
components underlying Bcl11b activation and comprehensively map the genetic interactions between these
components. More broadly, they will establish a widely-accessible viral system to concurrently turn on or off
genes in primary mouse immune cells, with broad applications in a variety of basic and translational applications.

Public health relevance
PROJECT NARRATIVE The immune system maintains distinct types of specialized cells to help the body defend against diverse threats. The proposed research will develop a genetic system to precisely turn on and off genes controlling the differentiation of different immune cell types. These systems will shed light into how immune cell types are established in the body, and ultimately help to better harness the immune system to fight diverse diseases.